Northwestern University Skin Disease Research Center Resource-based Center

Abstract: The Administrative Core, led by the Center Director, Dr. Amy S. Paller, and two Associate Center Directors, Drs. Rui Yi and Kurt Lu, will be responsible for coordinating all activities of the SBDRC. The Administrative Core will serve as a focal point for all cutaneous biology-related activities for scientists at Northwestern and nationally via an Enrichment Program that organizes seminars, workshops, lectures, and one-on-one interactions with distinguished visiting scientists. The Core will serve as a liaison with other Centers, including running joint conferences with skin-focused groups regionally (eg, the CounterACT Center and Chan Zuckerberg Biohub Chicago) and nationally (other SBDRCs). The Administrative Core will also maintain the SBDRC website and disseminate electronic communication, including through a newsletter and use of social media. The Core will continue to encourage investigators to enter the skin biology field and utilize Research Core services through the administration of a Pilot & Feasibility Program that funds three P&F grants per year. The Administrative Core will regularly review the other Research Cores (Skin Tissue Engineering and Morphology/STEM, Translating Experimental Skin Testing with Immune Tracing, Informatics, and Technology/TEST IT2, and Gene Editing, Transduction and Nanotechnology/GET iN) to assure quality, fiscal responsibility, cutting-edge science, and continued development of new services. The Core will also oversee all fiscal maintenance of Center resources, including service cost calculations and ensuring an overall balanced budget. The Administrative Core will accomplish all of these tasks with guidance from: (i) the SBDRC Executive Committee; (ii) the Executive Board (administrative oversight); (iii) an Internal Advisory Board (science oversight); and (iv) an External Advisory Board. Finally, the Core will continue to foster the training of young scientists in the field of skin biology and skin diseases through the continued mentorship of our junior members by more senior SBDRC bench research members and the Boards.

Public health relevance
Public Health Relevance: The overall objective of the Administrative Core is to coordinate and oversee all activities of the SBDRC. The Administrative Core organizes opportunities for learning, networking, and communication, provides pilot grants, and schedules meetings of Center leaders, Boards and scientists at Northwestern and nationally.